A Trauma-Informed Intervention for Positive Youth Development and Teacher Wellness in Rural Montana

This study is intended to help mitigate stressors that may contribute to poor behavioral and mental health in
high school–aged students and teachers. The immediate goals of this study are: 1) measure the physical
and mental health outcomes in adolescents resulting from a trauma-informed yoga intervention designed to
foster positive youth development; and 2) promote student health by supporting teacher wellbeing through
a concurrent, remotely delivered, trauma-informed yoga intervention. Aim 1: Expansion of pilot study to
teachers in the Livingston, MT, school district. Aim 2: Expand study to Livingston high school
students/teachers and use virtual delivery to rural schools in Park County, MT. Aim 3: Conduct outcome
and process evaluation to determine the most effective intervention design. Methods: This study will enroll
a minimum of 30 Livingston teachers (taught trauma-informed yoga via Zoom) in Year 1 and will aim to add
30 Livingston high school and rural Park County high school students and teachers to the intervention in
Year 2 (delivered via Zoom). Twice weekly 45-minute trauma-informed yoga sessions during the 6-week
intervention period will occur remotely (for teachers and Park County high school students) and face-toface
for Livingston students. To measure physical health outcomes, pre-, mid-, and post-intervention
cortisol testing will be utilized to evaluate any changes in student and teacher stress levels before and after
the program. Heart rate variability will also be assessed for students and teachers pre-, mid-, and postintervention
using the HeartMath Inner Balance PPG sensor and Em Wave Pro Plus software. To assess
behavioral health, pre- and post-survey instruments will collect targeted wellness/mental health data from
students and teachers. An Adverse Childhood Experience Self-Reporting Screener will also be given to
participants to establish a baseline of exposure to childhood trauma, which is closely correlated with health
outcomes (Burke-Harris, 2018). To assess teacher wellness, the same physical health data and similar
mental health assessments as students (focusing on depression and anxiety) will be collected, and
teachers will also complete the Teachers’ Sense of Self Efficacy Survey and the Professional Quality of Life
Index, which are linked to teacher mental health, retention, and career satisfaction. To explore scalability to
rural communities without access to yoga instructors, we will implement a limited feasibility study of online
yoga delivery to classroom teachers (both in Livingston and in rural Park County) and to students (in rural
Park County).

Public health relevance
The aim of this research is to improve mental and physical health outcomes for adolescents through a trauma-informed yoga intervention within the school setting. To support coregulation within the school classroom and teacher wellness, teachers in rural Montana will receive a similar, remotely delivered, trauma-informed yoga intervention. The study also seeks to strengthen school, community, and academic partnerships in order to reduce health disparities and improve student and teacher wellness.